Mechanism of transcription-coupled DNA repair and transcription mutagenesis

Recently, we demonstrated that yeast Pol II employs a distinct mechanism for CPD bypass (called A-rule) involving a conformational flexibility of its active center (the mobile trigger loop domain in Rpb1 subunit) facilitating accommodation of bulky lesions. We recently expanded this project to Pol II bypass of bulky cyclopurine (CyPn) oxidative damages in transcribed genes and to analysis of RTLS (RNA polymerase translesion synthesis) through the bulky lesions by mammalian (calf thymus, CT) Pol II. We also study transcription mechanisms enabling mammalian RNA polymerase II to transcribe through non-bulky oxidative DNA lesions such as 8-oxoguanine and 5-hydrohyuracil.